Core D - Data Management, Analysis and Product Development Support (CIIG)

PROJECT SUMMARY/ABSTRACT
The overall goal of Core D: Data Sharing, Analysis, and Product Development Support is to provide
CIIG Center projects and cores scalable centralized platforms, tools, and expert support services to efficiently
accelerate translation of Center-developed Neisseria gonorrhoeae (Ng) vaccine and therapeutic antibody
products from laboratory to humans. To accomplish this goal, a team of experts in data sharing and
collaboration platforms, study design and statistical analysis, and regulatory strategy and product development
from Research Triangle Institute (RTI) International has joined this Center to provide a comprehensive portfolio
of tools and support services in Core D. The Core D team will be led by Dr. Greg Sempowski, an immunologist,
vaccine/countermeasure developer, and long-standing collaborator in Neisseria gonorrhoeae vaccine research
and development of Drs. Jerse, Bash, Chackerian, Macintyre, and Criss. He will be joined by three
co-investigators in delivery of core services: Dr. Sean Hanlon, a computer scientist with an established track
record of using portal and dashboard technology solutions to support multi-disciplinary research initiatives; Dr.
Nathan Vandergrift, a statistician with experience supporting study design and statistical analysis for
non-clinical early phase research and development of infectious disease vaccines and therapeutics; and Dr.
Mark Levi, a medicinal chemist with experience as a pharmacology/toxicology researcher and regulatory affairs
specialist. Core D will support all CIIG projects and cores with three Specific Aims: 1) Develop and maintain a
central resource and data sharing portal to accelerate Center collaboration and product development; 2)
Provide study design, data analysis/statistical support to advance Center scientific rigor and data asset
dissemination; and 3) Provide regulatory strategy and product development support to shorten the translational
timeline for Center products to reach first in human trials. Through the successful delivery of services through
these Aims, Core D will support and accelerate CIIG vaccine and antibody product development to combat
Neisseria gonorrhoeae, a major antibiotic resistance public health concern.

Public health relevance
Project Narra+ve N/A